Targeting cell-to-cell communication to prevent bystander damage mediated by viral reservoirs

Abstract: “Targeting cell-to-cell communication to prevent bystander damage mediated by viral reservoirs.”
Soon after primary infection, HIV enters the CNS and causes long-lasting cognitive and motor
impairment in 30-60% of infected individuals, even in the current antiretroviral (ART) era. In the CNS, HIV
remains latent in a small population of microglia/macrophages and a smaller population of astrocytes. Our
human brain data indicate that long-term ART reduces the myeloid (microglia/macrophage) pool of viral
reservoirs (up to 23 years on ART). However, long-term ART did not reduce the astrocyte-infected pool.
Furthermore, chronic damage to uninfected cells was associated with glial viral reservoirs and amplified by
Connexin43 containing channels, gap junction (GJ) and hemichannels (HC), even in the absence of viral
replication. Our application focuses on astrocytes and the mechanism of bystander damage triggered by
viral reservoirs, even in the absence of replication.
Overall, our data indicate: First, a small population of latently infected astrocytes remain stable even
during long-term ART (up to 23 years in ART); Second, the few astrocytes with HIV-integrated DNA are
associated with localized inflammatory areas; Third, HIV-infected astrocytes survive apoptosis for extended
periods; Fourth, we demonstrated that few infected astrocytes could repopulate the entire body with the
virus and Fifth, we demonstrated that connexin containing channels, GJ and HC, amplify chronic
inflammation into neighboring uninfected cells by a mechanism involving compromised calcium/IP3
signaling, mitochondrial function, and inter-organelle interactions (ER, mitochondria and lipid bodies); and
Lastly, we demonstrated all these toxic mechanisms could be prevented by reducing GJ and HC
communication between viral reservoirs and surrounding uninfected cells.
We hypothesize that “HIV-latently infected astrocytes used GJ and HC to amplify toxicity into
neighboring uninfected cells even in the current ART era.” The results obtained from this proposal will lead
to identifying potential therapeutic targets to limit the devastating consequences of NeuroHIV.

Public health relevance
Narrative: As individuals with HIV live longer due to antiretroviral therapies' success, the prevalence of cognitive and motor deficits in the infected population is increasing. Astrocytes play a key role in maintaining most CNS functions in physiological conditions, but their importance in the pathogenesis of NeuroHIV has not been well characterized and remains controversial. However, our group demonstrated that glial viral reservoirs use gap junctions (GJ) and hemichannels (HC) to spread toxicity into neighboring uninfected cells despite their low numbers and minimal to undetectable viral replication.